the Integrative and Multidisciplinary Pain and Aging Research Training (IMPART) Program

Abstract
Chronic pain represents a major public health concern, and aging confers increased risk for chronic pain, with
half of older adults reporting persistent or recurring pain, and aging is associated with greater pain-related loss
of physical and psychosocial function. Current knowledge regarding pain and aging is surprisingly limited, and
future progress in the field hinges on the availability of well-trained scientists who have an appreciation for
preclinical and clinical research approaches to the study of both aging and pain. To address this unmet need,
we developed a new postdoctoral training program: the Integrative and Multidisciplinary Pain and Aging
Research Training (IMPART) Program, and we propose to extend and expand this program via this competing
renewal. The overall goal of the IMPART program is to develop outstanding independent investigators capable
of sustaining productive clinical and translational research careers addressing the biopsychosocial mechanisms
underlying age-related changes in the experience of pain and/or designing clinical interventions to ameliorate
acute and chronic pain among older adults. In order to accomplish this overarching goal, the specific aims of this
new postdoctoral training program in pain and aging research are to: 1) Recruit and train promising junior
investigators to conduct mechanistically-based and clinically relevant translational research in pain and aging;
2) Implement an integrated didactic and experiential training program, which will equip trainees with new
research skills and the knowledge and expertise to apply these skills to address important and unanswered
questions regarding pain and aging; and 3) Create a culture of research excellence in order to ensure that
trainees aspire to the high standards of scientific integrity and quality, which will set the tone for their future
careers in pain and aging research. IMPART leverages two excellent and collaborative research programs at
the University of Florida – the aging research community represented by the Institute on Aging (IOA), and the
pain research community, organized under the Pain Research and Intervention Center of Excellence (PRICE).
We have been highly successful in recruiting and training an outstanding and diverse group of trainees during
the initial funding cycle. Each member of the training faculty boasts an excellent track record of both research
funding and mentoring experience. The proposed program requests support for six postdoctoral trainees from
a variety of training backgrounds, each of whom will work with their multidisciplinary mentoring team to create
and implement a tailored independent development plan as the blueprint for their training. Trainees will achieve
their research and career development objectives through a combination of didactic, research, and professional
development activities, and program evaluation will be ongoing and multimodal. The IMPART Program is
committed to promoting diversity among our trainees, and the program will provide a training experience that
emphasizes excellence in research integrity and ethics.

Public health relevance
Narrative Chronic pain represents a major public health problem disproportionately impacting older adults and an improved understanding of the neurobiological and psychosocial mechanisms underlying age-related changes in pain is critical to inform interventions aimed at reducing pain in the elderly. At present, there is a deficit of scientists trained to conduct clinical and translational research investigating pain and aging. In order to address this gap, we propose to continue our Integrative and Multidisciplinary Pain and Aging Research Training (IMPART) postdoctoral training program with the long-term goal of creating the next generation of pain and aging scientists who will move the field forward through cutting edge research designed to elucidate and ameliorate adverse age-related changes in the experience of pain.